The role of glucose homeostasis during respiratory infections

PROJECT SUMMARY
While diabetes has reached epidemic levels, respiratory infections, such as influenza, have long held a high spot
on the list of worldwide causes of death. Diabetes, which is defined by a persistent hyperglycemic state, leads
to multiple organ complications. Importantly, hyperglycemia is a major and independent risk factor for the
development and worsening severity of pulmonary infection, including influenza infection. This phenomenon is
thought to occur due to the hyperglycemic state predisposing patients to a higher-than-normal glucose
concentration in the airway, leading to an increased risk of pulmonary infections. Although the lung is a major
organ to utilize glucose, the role and the regulation of glucose homeostasis in the lung have received little
attention. Therefore, our long-term goal is to investigate the role and alterations of glucose homeostasis that
occur during respiratory infections. Glucose uptake from the bloodstream, the rate-limiting in glucose utilization,
is tightly regulated by a family of specialized proteins, called glucose transporters (GLUTs). Because every cell
expresses these GLUTs, they are recognized as major regulators of whole-body glucose metabolism and thus
are key pharmacological targets. However, little is known about the regulation of glucose transport and utilization
in the respiratory system, particularly during a hyperglycemic state. Importantly, we recently demonstrated that
the expression and activity of several major and novel GLUT isoforms were altered in the lung during diabetes,
as well as the downstream insulin signaling pathway. We further showed that diabetic mice possess higher viral
titers in the bronchial alveolar lavage fluid following influenza infection. Therefore, the overall goal of this project
is to understand how alterations in pulmonary glucose homeostasis during diabetes enhance viral replication
and thus the pathogenesis of influenza. The specific aims of this project are to test the hypotheses that: 1)
impaired glucose transport and utilization enhances influenza infection in the lungs of diabetic animals; and 2)
alterations of the insulin signaling pathway in the diabetic lung enhance the inflammatory response and the
severity of influenza infection. We will use a comprehensive, integrated approach at multiple system levels using
state-of-the-art techniques and the CoBRE Core Facilities. An interdisciplinary mentoring team will also provide
the applicant with an intensive collaborative research experience in the rich intellectual environment at Oklahoma
State University and at the University of Oklahoma Health Sciences Center. Insights gained from this study could
lead us 1) to establish a novel mechanistic link between diabetes and influenza infections; and 2) to identify
novel metabolic therapeutic targets for viral influenza infections, a crucial outcome of this project. Finally, by
capitalizing on her strong dual training in basic and clinical sciences, this award is designed to foster the
development of the applicant toward achieving her career goals in the field of respiratory and infectious diseases.